Development Core

DEVELOPMENT CORE
Abstract
The Development Core stimulates and supports new HIV science and scientists through a variety of essential
services that promote and facilitate research development and research careers. The Pilot Project Program
provides small grants to CIRA affiliates; the Peer Review Program provides expert guidance and feedback on
grants, manuscripts, and presentations for CIRA affiliates; and the Visiting Fellow program promotes
international collaborations in high impact areas. The Core also supports several HIV training programs for
junior scientists that are affiliated with CIRA and located in our Center(e.g., T32, R25, D43). Through its role
with CIRA-affiliated training programs, the Core facilitates and expands access to resources that are essential
to the successful conduct of HIV research, including community-based and community-engaged research and
fosters a positive, enriching environment for aspiring HIV researchers and particularly those underrepresented
in the field and/or those seeking to focus on HIV disparities in their research, in areas and with populations
most impacted by HIV. CIRA’s Mentored Network of HIV Scholars provides additional support and structure
for early-career CIRA affiliates to help them build their professional network, develop a robust professional
support system, and help traverse challenging academic and funding systems. The Development Core will
integrate health equity approaches (e.g., implementation science, community-engaged research, anti-racist
mentorship) within all Development Core activities to help ensure that CIRA-affiliated research contributes to
equitable advances in HIV prevention. Through the proposed activities, the Development Core will make a
significant and unique contribution to CIRA’s mission of supporting research leading to sustainable impact on
equity-enhancing practice and policy. Through expanded services such as the Mentored HIV Scholars
Network, the Core will also ensure that CIRA’s 25 years of deep impact on supporting innovative research and
passionate trainees continues and spreads across communities most in need of an equitable approach to HIV
research and training.